Establishing iPSC-based models to investigate the mechanistic interaction between neurotrauma and ALS/FTD

Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are devastating neurological disorders
with limited treatment options. A hexanucleotide intronic (G4C2)n repeat expansion in C9orf72 is the most
common genetic cause of ALS and FTD. However, patients with C9orf72 mutations are characterized by clinical
heterogeneity and variable penetrance. The nature of this variability is not well understood but environmental
factors have been proposed to act as an additional trigger beyond the pathophysiology associated with the
C9orf72 repeat expansion. Moreover, 90% of ALS/FTD cases are classified as sporadic and likely arise from an
interaction between genetic predisposition and environmental factors. One such environmental factor is
neurotrauma, which results from traumatic brain or spinal cord injury and has been shown to substantially
increase the risk of ALS/FTD in epidemiological studies. The association between traumatic injury and ALS/FTD
is exemplified by the shared neuropathology TDP-43 aggregation. TDP-43 is a predominantly nuclear RNA
binding protein involved in RNA transport and splicing, that forms cytoplasmic aggregations in more than 98%
of ALS cases. Widespread TDP-43 aggregation is also seen in patients who have suffered traumatic brain injury
(TBI). While these observations indicate a potential link between these diverse neurodegenerative diseases, it
is unclear whether the mechanisms that drive TDP-43 pathology in ALS and TBI are shared or divergent. What
also remains unclear is whether an ALS genetic background confers heightened vulnerability to neurotrauma.
Here, we will use ALS/FTD patient-specific induced pluripotent stem cell (iPSC) derived neuronal cultures in
combination with a custom-built device that applies biofidelic mechanical stretch-induced trauma in vitro, to
establish novel human models that mimic the impact of traumatic injury. The innovative instrument can effectively
recapitulate a key facet of TBI in diffuse axonal injury. In key preliminary work we found that C9orf72, but not
isogenic control motor neurons exhibit selective degeneration and extended cytoplasmic accumulation of TDP-
43 in response to trauma. In Aim 1 we will interrogate several ALS C9orf72 iPSC lines and controls to test the
hypothesis that stretch-trauma exacerbates C9orf72 pathology. We will measure both sense and antisense
transcript and dipeptide repeat protein production in response to varying degrees of traumatic injury. We will
investigate the ability of sense and antisense targeting ASOs to protect neurons from injury to dissect the relative
contribution of these mechanisms to stress-induced mutant C9orf72 toxicity. In Aim 2 we will generate spinal
and cortical neurons from 12 sporadic ALS and 12 age/gender matched control iPSC lines and interrogate their
ability to cope with varying degrees of mechanical trauma. We will examine neuronal survival, the subcellular
localization, solubility and functionality of TDP-43 protein using biochemical and RNA-Seq approaches. Our work
will capture the interaction between mechanical trauma and an ALS/FTD genotype in a controlled environment
that allows definitive hypothesis testing and mechanistic experiments

Public health relevance
Traumatic injury of the brain and spinal cord has been associated with an increased incidence of Amyotrophic Lateral Sclerosis (ALS) and frontotemporal dementia (FTD) through epidemiological studies. However, the mechanistic link between trauma and interaction with an ALS/FTD genetic background remain unexplored. Here, we will use stem cell-based technology in combination with a custom-built device that applies biofidelic mechanical trauma to establish novel human models and elucidate the connection between neurotrauma and ALS/FTD neurodegeneration.